Orbitofrontal cortical coordination of action-consequence decision making

SUMMARY
Goal-directed actions are behaviors directed towards achieving outcomes of high value. Individuals who
experience early-life adversity instead favor habit-based behaviors that are insensitive to reward value. Such
insensitivity can contribute to depression and its diverse symptoms, including anhedonia and social withdrawal.
A primary goal of the parent R01 is to understand the mechanisms by which social isolation disrupts
goal-directed decision making. Major discoveries are: 1) social isolation in adolescence causes failures in
goal-directed decision making later in life. 2) Dendritic spine plasticity (or lack thereof) on neurons within
coordinated cortico-amygdala circuits causally contribute to failures in the ability of mice to select actions based
on the likelihood that they will be rewarded with valued outcomes.
My lab simultaneously developed tests for understanding the capacity of social experiences to modulate
goal-directed actions – for example, a couple might routinely visit a particular restaurant because it is where they
had their first date. Mice are trained to respond for two equally preferred food reinforcers in operant conditioning
chambers. Then, one food is paired with a novel conspecific, while the other is paired with a novel object. When
returned to the conditioning chambers for a probe test, mice prefer the food associated with the novel conspecific.
Thus, we have in hand a procedure that quantifies the social incentivization of future choice (SIFC) in mice.
Under the parent grant, the lab initially focused on orbitofrontal cortical control of action. Interestingly, though,
the team found that SIFC instead requires the adjacent prelimbic prefrontal cortex (PL) and its interactions with
the basolateral amygdala (BLA). For instance, inactivation of PL-to-BLA projections obstruct the ability of social
interactions to confer value to external rewards. This exciting finding inspired my proposal to: (1) define the
mechanisms controlling value-based action and its influence by social experiences, focusing on PL-BLA
interactions. I will test the hypothesis that excitatory input onto BLA neurons from the PL triggers dendritic spine
plasticity on BLA neurons, which is required for SIFC. Then, I will team with Emory collaborator Dr. Malavika
Murugan to leverage in vivo cellular resolution calcium imaging and genetically encoded calcium indicators to
infer what types of information neuron populations within PL-BLA circuits encode.
(2) I will then determine whether social isolation during adolescence derails the ability of social experience
to incentivize later goal-seeking behavior, with the hypothesis that social isolation disrupts the capacity of social
interactions to later incentivize goal-directed choice. Positive outcomes now, during the initial years of my PhD
training, will position me as I enter advanced training to better understand long-term consequences of social
poverty and develop strategies to improve goal-seeking capacity in mice with a history of social isolation. In light
of social isolation imposed by the ongoing COVID crisis, understanding how social isolation impacts varied
decision-making behaviors is timely and important.

Public health relevance
NARRATIVE Goal-directed actions are behaviors directed towards achieving outcomes of high value. Individuals who experience early-life adversity instead favor habit-based behaviors that are insensitive to reward value. This proposal will understand how social experiences impact goal-directed choices, and how social isolation disrupts this process.